How Peripheral Vestibular Signals Create Vestibular Compound Action Potentials

Project Summary
Type I and type II hair cells within sensory epithelia of semi-circular canals and otolith organs transduce head
motion into electrical signals used in the coordination of gaze, orientation, and motor movement. These signals
are transmitted to the vestibular nuclei, cerebellum, and neural circuits that inform the vestibulo-ocular reflex and
the vestibulo-collic reflex. Type I hair cells transmit to chalice like (calyx) terminals of primary afferent neurons
through neurotransmitter dependent (quantal) and independent (non-quantal) means. The latter occurs through
the modulation of post-synaptic currents via changes in synaptic cleft electrical potential and potassium ion
concentration following hair cell stimulation. At present, I study the interaction of quantal and nonquantal
transmission in calyx afferents. Next, I aim to connect signal generation in the periphery to in-vivo measures of
vestibular activity such as the vestibular compound action potential (VCAP).
In-vitro action potential (AP) generation by calyx afferents, in response to hair bundle displacement, is relatively
low pass filtered (<100 Hz). However, in-vivo measures indicate that calyx afferents generate AP during high
frequency (>100 Hz) air conducted sound (ACS) and bone conducted vibration (BCV) stimulus. The goal of this
independent proposal is to reconcile these observations. I will create a representative tile of the vestibular
epithelium that contains multiple hair cells and afferents and study how firing of nerve fibers emerging from the
tightly packed vestibular epithelium shapes VCAPs in spaces adjacent to the vestibular nerve. This approach
will identify the mechanisms underlying the discrepancy between in-vitro, electrophysiological recordings from
calyx afferents in semi-intact preparations of vestibular epithelia and in-vivo measurements of VCAPs and scalp
recordings during rapid head motion. This research will build fundamental knowledge on how to use the VCAP
for diagnosis and treatment of vestibular disorders such as age-related vestibular dysfunction (ARVD) in which
a loss of extrastriolar calyceal synapses is reported.
The computational, mechanistic, model of how peripheral vestibular signals shape the VCAP will be developed
using COMSOL and MATLAB. The proposed model overcomes several challenges involved in simultaneously
studying the VCAP and observing peripheral function in-vivo: 1) There is no need to mask for or separate
cochlear contributions to the measured electrical signal during ACS or BCV stimulus; 2) The activity and electrical
contributions from individual hair cells of differing response polarity and their associated neurons can be tracked;
3) VCAP and vestibular microphonics from regions of the otolith organs or semi-circular canal cristae can be
modelled separately without the need to expose vestibular compartments. The outcome will be a model capable
of informing vestibular implant stimulation strategies and studying of how vestibular channelopathies and
damage may alter VCAPs.

Public health relevance
Project Narrative Electrical measurements of vestibular function such as the vestibular compound action potential (VCAP) are analogous to clinical tests of hearing such as the evoked compound action potential (eCAP). However, the use of VCAPs to interpret activity in the peripheral vestibular system and related pathologies is underdeveloped as the relation between VCAP features and peripheral vestibular signal generation is unclear. Computational modelling will be used to simulate and study how peripheral vestibular signals shape the extracellular electrical potential fluctuations around the vestibular nerve to form VCAPs.